Mucosal immune biomarkers to detect neonatal leaky gut

PROJECT SUMMARY
Necrotizing enterocolitis (NEC) is a life-threatening, gastrointestinal emergency affecting 7-10% of preterm
infants with mortality as high as 30-50%. "Leaky gut", or intestinal barrier immaturity with elevated intestinal
permeability (IP), is the proximate cause of susceptibility to NEC in preterm neonates. Early detection of leaky
gut is essential to identify infants at risk for NEC to reduce disease severity. No clinical factor, routine laboratory
test or biomarker alone or in combination have been described that identify newborns susceptible to develop
NEC. We postulate that a mucosal immune phenotype detectable in fecal extracts, is reflective of the intestinal
microenvironment and postnatal barrier maturation and can distinguish infants at high risk for developing NEC.
The goal of this study is to investigate the diagnostic value of fecal immune biomarkers to identify “at-risk”
neonates with leaky gut prior to NEC onset. When used alone or in combination with other IP-associated neonatal
factors (i.e., postmenstrual age, feeding, microbiota), the immune phenotype can provide the basis of a non-
invasive, stool-based method to detect neonatal leaky gut. To achieve this goal, we will leverage existing stool
samples collected from a cohort of 205 preterms (<33 weeks gestation), from whom both gut microbiome (16S
rRNA gene sequencing and metagenome) and IP (urine non-metabolized sugar probes lactulose and rhamnose)
are known. Two aims are proposed: 1) to conduct an in-depth characterization of cytokines and chemokines in
fecal extracts of preterm infants during the first 7-10 days of life, and to determine the diagnostic value of fecal
immune biomarkers in identification of aberrantly elevated IP as a major risk factor for NEC; 2) to define
longitudinal changes of fecal immune biomarkers associated with improved or persistently elevated IP. At the
completion of this study, we will have identified a discriminatory mucosal immune phenotype representing a
novel, non-invasive stool-based diagnostic/screening tool to identify preterm newborn “at risk” for developing
NEC. This study will also provide new insights into the interplay between host immunity and gut microbiota
dysbiosis that contributes to heightened barrier injury in early life. These results will facilitate clinical studies to
evaluate rationally designed interventions for early NEC prevention and to promote healthy intestinal barrier
functions and newborn health.

Public health relevance
PROJECT NARRATIVE "Leaky gut" is the proximate cause of susceptibility to necrotizing enterocolitis (NEC), a life-threatening, gastrointestinal emergency affecting 7-10% of preterm infants with mortality as high as 30-50%. This proposal seeks to establish a stool-based immune profile that can identify “at-risk" preterm infants with hyperpermeable intestinal barrier prior to the onset of NEC. The results of this study would facilitate clinical evaluation of preventive and therapeutic measures aimed at improving intestinal maturation and reducing the burden of NEC complications.